ROLE OF HOST AND VIRAL FACTORS IN RESISTANCE TO RABIES VIRUS INFECTIONS IN MICE

The principal objective of these studies is to determine host and viral factors that influence the genetically-controlled resistance of inbred mouse strains to street rabies virus (SRV). Studies concerning the importance of interferon induced within the central nervous system (CNS) during infection as a mechanism responsible for resistance have been completed. The interferon was characterized as a typical viral-induced pH 2.0 stable type l interferon with alpha and beta specificity. Furthermore, it was determined that the high concentrations of interferon-alpha/beta that were induced by SRV in the CNS of susceptible A/WySnJ mice were ineffective in inhibiting viral relication. The 100% survival of SRV-infected resistant SJL/J mice following neutralization of interferon within their CNC with high concentrations of rabbit anti-mouse interferon-alpha/beta suggested that the minimal amount of interferon present in the CNS during infection was not the mechanism responsible for their innate resistance to ip-inoculated SRV. Studies concerning the significance of cellular immunity have progressed with the development of a 8 hr assay that measures specific cytotoxic T-cell killing. Maximum killing occurs following a 5 day in vitro incubation of 1X108 spleen cells with 1X106 137Cs-irradiated rabies virus-infected stimulator cells; effector to target (E:T) ratios of 10 and 5 result in >70% and >40% specific lysis, respectively. The assay has been simplified by using P815, EL-4 and mouse neuroblastoma target cells persistently- infected with ERA virus. We have demonstrated specific T-cell cytotxicity with lymphocytes from susceptible A/WySnJ and C57Bl/6J mice and resistant DBA/2J and BALB/cByJ mice. Preliminary results suggest that maximum cytotoxic T-cell activity occurs seven days after ip-infection with ERA virus grown in CER cells. Mice infected with similar concentrations of SRV, CVS, and ERA viruses inoculated ip. as 10% mouse brain suspensions have minimal T-cell activity. We have been unable to demonstrate specific T-cell killing in an 8 hr assay with uncultured lymphocytes. The emphasis of these studies will be to continue to investigate the importance of cytotoxic T cells in murine resistance to SRV infections.